Computational evaluation of the causal role of somatic mutations in human aging

Project Abstract
Although genome instability has long been considered as one of the major causal factors of aging, little is
known about the actual number of genome alterations per cell and their effects on aging organisms, most
notably humans. In the research proposed here I will take a single cell approach to identify the most common
types of somatic mutations, i.e., base substitutions, small INDELS, copy number variation, genome structural
variation and retrotranspositions, in human B lymphocytes as a function of age. The overarching goal is then
to estimate functional effects of these DNA mutations accumulated during human aging in this
particular cell type, which will also serve as a model for studying somatic mutations and their
consequences in other cell types. This could never be tested before, because it was never possible to
analyze random somatic mutations in a tissue by sequencing bulk DNA from that tissue (mutations are low-
abundant), I will achieve this goal by utilizing a new, single-cell, whole genome sequencing (SCWGS) protocol
that we developed. In this project I will focus on human B lymphocytes from individuals varying in age from
about 30 to over 100 years and determine the genome-wide frequency and location of the different types of
mutations in multiple cells from each individual (Aim 1). Preliminary results already show a significant increase
of both base substitution mutations and CNVs with age, with a substantial number of these mutations in B cell
genomic regions that are potentially functional. Hence, in Aim 2 I will predict the actual functional effects of
these potentially functional, age-related mutations using machine learning approaches and integrative network
analysis. Finally, in Aim 3 I will empirically test these predictions as to whether the mutation loads observed
affect B cell's ability of response to stimulus. Hence, to test the long-standing hypothesis of genome instability
as a causal factor in aging ,I will determine age-related mutations in single cells at four levels: (1) number of
mutations, mutation spectra and genome distribution in individual cells; (2) potential functional effects of
individual mutations, i.e., non-synonymous mutations in exons and mutations in gene regulatory regions; (3)
mutations collectively affecting the gene regulatory network; and (4) relationship between mutation load and B
cell activation status. In summary, the results of the proposed project will, for the first time uncover possible
direct functional effects of somatic mutations on cellular function.

Public health relevance
Project Narrative Genome instability is considered as one of the major factors of aging and age-related diseases. This research aims to study somatic DNA mutations in normal blood cells (B lymphocytes) of humans of different ages and evaluate the functional effect of these mutations. It will dramatically improve the knowledge of DNA mutations in aging and deepen the understanding of genome instability as a basic aging mechanism in human.